Harvard Clinical and Translational Science Center (TL1)

The education of Clinical Translational (C/T) researchers is a life-long process that begins in undergraduate years, extends to graduate students, medical students, residents, and fellows, and involves both junior and senior faculty. In planning for this application, we intensively reviewed existing C/T research training programs at Harvard. We noted 3 major limitations: our existing programs serve a relatively select group of trainees;are poorly integrated;and insufficiently emphasize career mentoring and guidance, particularly for junior faculty. The lack of central coordination has resulted in a multitude of "siloed" programs in each Academic Health Center (AHC), creating programs insufficiently nimble to accommodate the rapidly evolving scientific and regulatory aspects of C/T research and failing to fully utilize the depth and breadth of Harvard's resources. Inspired by the pan-institutional mandate of the CTSA, in December 2006 we established the Clinical and Translational Research Education Program (CTREP) to serve as the hub and portal for all C/T education and training programs at Harvard. CTREP has catalogued curricula from undergraduate through faculty levels across Harvard and convened all program directors to discuss gaps and barriers. This process has resulted in the development of new programs and the integration of training opportunities. Building on this promising beginning, we have established a new Harvard-wide Education and Training Executive Committee (ETEC) that will coordinate, integrate, and govern C/T education, training, and career development throughout Harvard. We will use the CISC to create programs where none exist and to modify and coordinate meritorious established programs, building a continuum of educational opportunities throughout the career of the C/T researcher. These programs will facilitate new linkages between C/T and other intellectual disciplines throughout Harvard University. We will treat mentoring as an integral and essential part of education, developing individualized models for career development and continuing education.